Evaluating the Influence of Culture and Risk Perception on HPV Vaccination Intention among Haitian Immigrant Women Living with HIV

Evaluating the Influence of Culture and Risk Perception on HPV Vaccination Intention among Haitian
Immigrant Women Living with HIV
PROJECT SUMMARY
Cervical cancer is the primary cause of cancer-related deaths among women living with HIV. Haitian immigrant
women have one of the highest incidence rates of cervical cancer in the nation and are disproportionately
affected by HIV. The dual disease burden of HIV and cervical cancer that Haitian immigrant women experience
is critical to note as HIV significantly increases the risk of developing cervical cancer. Cervical cancer can be
prevented through immunization with the human papillomavirus (HPV) vaccine, however HPV vaccine uptake
in this community is excessively low despite their high risk. Research has noted a link between individuals’
perceived risk of cancer, and their intention of undergoing cancer prevention behaviors. Recent studies have
highlighted a key role of affect (i.e. emotions), feelings, and thoughts, which are influenced by cultural
worldviews, in the rapid, automatic formulation of cancer risk perceptions and cancer prevention behaviors.
Studies have continuously highlighted the disparities in cervical cancer incidence rates among Haitian
immigrant women, along with Haitian immigrant women’s low uptake of cervical cancer prevention measures.
However, literature has been limited to date in evaluating the psychosocial and cultural factors that influence
Haitian immigrant women’s intention of undergoing HPV vaccination. More specifically, cultural worldviews and
affective risk perceptions towards HPV and cervical cancer, and the influence these factors have on HPV
vaccination intention, are largely unexplored among Haitian immigrant women living with HIV. The aims of this
study are: 1) To qualitatively explore cultural worldviews and affective risk perception on HPV vaccination
intention. Cultural worldview items will be developed from qualitative data. 2) To examine whether predictors
of HPV vaccination intention (e.g. cultural worldviews, affective risk perception, individual level factors) will
differ among Haitian immigrant women based on HIV status 3) To converge qualitative and quantitative
findings to understand how affective risk perceptions and cultural worldviews influence HPV vaccination
intention among Haitian immigrant women. The contributions of the present proposal are significant as this
study will be one of the first to comprehensively assess the role of risk perception as a motivator of health
behaviors related to HPV vaccination in this high-risk community.

Public health relevance
Evaluating the Influence of Culture and Risk Perception on HPV Vaccination Intention among Haitian Immigrant Women Living with HIV Project Narrative Affective dimensions of risk perception and cultural worldviews may have a significant role in Haitian immigrant women’s intention of undergoing HPV vaccination. When there is no prior experience of a disease, and minimal knowledge is available, emotions along with cultural influences can shape an individual’s appraisal of their disease risk and guide their behavior decisions. This proposed study aims to understand how affective dimensions of risk perception, which are shaped by cultural worldviews, influence the HPV vaccination intention among Haitian immigrant women with and without HIV.